The function of dopamine and striatal neurons in guiding behavior in uncertain environments

Project abstract
Animals must acquire and integrate information over time in order to make decisions. In addition, as the
environment changes, animals must use new information to update previous models of the world and revise
their decision making process. We observe such decision making processes in mice by challenging them to
use changing and probabilistic environmental information to choose a motor action to achieve water rewards.
These tasks engage the striatum and evoke dynamic dopamine signaling which is thought to be crucial to the
decision making process. Here we will use modern methods of analysis of motor action with simultaneous
observation of bilateral activity in the dorsal and ventral striatum to understand how features of behavior, the
environment, and reward history are encoded in the striatum during dynamic decision making. Our predictions
highlight the potential importance of hemispheric asymmetry in striatal dopamine, SPN and PKA activity in
action selection, motor behavior and stochasticity of choice. We will further test these predictions using use
time locked perturbations of activity to understand the causal relationship of these signals to ongoing and
future behavior.